Tissue Engineering Resource Center: TTD

SUMMARY
For TERC renewal, the Technology Training and Dissemination Core has been designed to provide three related components: training, dissemination and outreach. Training will provide investigators with the knowledge and skills necessary for effectively using TERC developed technologies, and to create a new cadre of biomedical researchers prepared to move the field forward. To this end, we will offer graduate-level courses (e.g., hands-on laboratory classes, stem cell bioengineering class) for developing general tissue engineering skills. In parallel, we will offer specialized seminars, lectures, symposia and workshops tailored to the needs and interests of the trainees (e.g., specialized trainings in translational research, clinical research, entrepreneurship and commercialization). We will also offer research programs for undergraduate, graduate and medical students, and residencies for guest investigators. A portfolio of training modalities will be posted on TERC website, with regular updates and made available free of charge. The second component - dissemination will also include a range of modalities that will be managed through the TERC website. Our weekly lecture series Tissue Talks will continue to be offered to worldwide audiences, by Zoom, at no cost. Workshops and symposia organized by faculty and trainees will continue to be offered to all registered participants to provide forums for discussing developments in the field. Science Simplified, a web-based initiative started and managed by TERC trainees, will feature recent advances in tissue engineering, in form of clear and simple articles suitable for young audience and non-specialists. The Career Conversations Podcast, also run by our trainees will provide invaluable insights into the multiple career paths (please see nextgenTERC.com).